Transposable element mobilization during spermatogenesis in Drosophila

Abstract
Transposons are mobile pieces of DNA that comprise significant proportions of eukaryotic genomes, including
around 45% of the human genome and 30% of the fly genome. While most transposons have lost the ability to
jump into new locations in the genome, several in each organism maintain the ability to mobilize. New transposon
insertions are particularly consequential if they are generated in germline cells. Germline insertions are
subsequently present in every cell of the organism they develop into and can be passed on to future generations.
Thus, germline cells employ multilayered mechanisms to repress transposons. These repressive mechanisms
are essential to largely suppress transposon for development of germline cells into mature eggs and sperm
because transposon activity can contribute to sterility. Since these repressive mechanisms like the piRNA
pathway render transposition events so rare, they are difficult to detect and our understanding of how
transposons mobilize in the germline remains incomplete. Namely, the host factors that transposons employ to
generate new insertions and the time point when they make new insertions during sperm maturation are
undefined. To find potentially active transposons in the male germline, I have sequenced circular DNA from
Drosophila testes with the piRNA pathway depleted. Disrupting the piRNA pathway allowed for transposon
activation and revealed that the nomad transposon generates the most circular DNA in the testes. Circular DNA
is a transposition intermediate of LTR retrotransposons and its presence can indicate the likelihood of a
transposon being able to still make new insertions. With the knowledge that nomad is the most active transposon
in the male germline, I propose to use this transposon to study how transposons mobilize in the germline. I
hypothesize that transposons utilize host factors from the alt-EJ DNA repair pathway to achieve stage specific
mobilization during spermatogenesis. I will utilize circular nomad DNA as a readout to find host factors required
for its production and transposition reporters for nomad to precisely identify when it generates new insertions.

Public health relevance
Project Narrative Transposons are pieces for DNA that move to new locations in the genome and can rewrite an organism’s genetic code, but their activity in the germline can also contribute to sterility. The mechanism of how these elements can complete their life cycle in germline cells is incomplete. The experiments outlined in this proposal will define the host factors used for transposition and the window of time when transposons generate new insertions.